Defining the molecular interface of Wolbachia Ankyrin-host interaction

PROJECT SUMMARY/ABSTRACT
Wolbachia pipientis is an obligate intracellular alpha-proteobacterium that infects 40-60% of insect species on
the planet. Wolbachia infection inhibits RNA virus replication in insects, a phenomenon known as pathogen
blocking. Therefore, Wolbachia infected mosquitos are being released in many parts of the world to control the
spread of human diseases. Importantly, although the mechanism behind Wolbachia’s virus inhibition is not
known, Wolbachia must manipulate host biology to infect new hosts, persist, and be transmitted to the next
generation. Our long-term goals are to identify the molecular toolkit used by Wolbachia to establish infection
and the host targets of these tools; to define the co-evolution of that molecular interface. To that end, we focus
on the ankyrin repeat containing proteins found in Wolbachia proteomes. Our hypothesis is that via these
effectors, the host cell is modified, allowing Wolbachia to invade and persist.
Our preliminary data identified multiple ankyrin repeat containing proteins in Wolbachia (WARPs) and
established their phenotypes in Drosophila melanogaster. Wolbachia strain wMel encodes 25 such proteins
and we see striking phenotypes upon overexpression in the fruit fly. The phenotypes are dependent on the
ankyrin repeat domain, establishing its importance in binding host targets. These results led to our central
hypothesis that Wolbachia uses WARPs to modify the host cell environment and that these ankyrin repeat
proteins have evolved across the clade, as Wolbachia has spread to new host backgrounds. Towards this
hypothesis, we have begun several large-scale screens to identify host targets for the WARPs and
suppressors of toxicity for these secreted effectors. We have already identified some direct interactions
between WARPs and Drosophila proteins and look to further define the molecular interface between symbiont
and host using evolution-guided chimeras and molecular biological assays such as bacterial-2-hybrid and
reciprocal co-IPs.
Guided by strong preliminary data, we propose to pursue three Specific Aims to identify and characterize
WARP-target interaction, and their co-evolution, using the power of the Drosophila system. We will (1)
determine WARP targets (2) identify the relevance of WARPs and their targets to Wolbachia and host biology,
and (3) define the co-evolution of the host-symbiont molecular interface.
Studies of Wolbachia - host interactions are still in their infancy despite the recognized contributions of
endosymbiotic associations to insect reproduction and evolution, and the ability to alter vector competence.
These proposed studies will significantly advance our understanding of how Wolbachia manipulates host
biology to establish infection, a necessary prerequisite to its use in vector control.

Public health relevance
PROJECT NARRATIVE Wolbachia pipientis is a bacterium that infects 40-60% of all insect species on the planet, including important insect vectors, where it inhibits virus replication. Our proposed studies aim to identify the molecular interface between Wolbachia and its hosts using the ankyrin repeat domain and its evolution across the clade. Discoveries made as part of this work will help us understand how an extraordinarily widespread symbiont has become so successful.